Development of a Shared Decision Making Support (SDM-S) Measure for Use with Team-based Care

Abstract
As health care has become more complex, shared decision making (SDM) becomes increasingly important
and is now required by the Centers for Medicare and Medicaid Services (CMS) prior to reimbursement for
some services. Despite such requirements, we do not yet have a way to monitor the quality of medical
decision-making in today’s practice environment. This void limits the impact of policies requiring the use of
SDM as well as the ability to either foster SDM or understand its effects in practice. In this application, we build
on our team’s clinical and medical decision-making expertise to develop valid and psychometrically sound,
patient-reported SDM-support (SDM-S) measures that consider four distinct, decision-making phases (i.e.,
choice awareness, consideration of alternatives/preferences, choice-making, and choice implementation), and
the language used by patients to describe how decision making unfolds in practice. In so doing, we seek to
advance the SDM measurement field from a researcher, single scale orientation to a multiphase/multi subscale
orientation that explicitly considers the decision-making support patients describe receiving from their physician
and different care team members across each of the decision-making phases from decision awareness to
choice implementation. Such an orientation is needed as providers and others explore new and innovative
ways to implement and monitor SDM in practice. We use mixed-method and user-centered design approaches
to develop the measures and test their performance across four preference-sensitive cancer care contexts:
lung cancer screening, colorectal cancer screening, rectal cancer treatment, and prostate cancer treatment.
We evaluate scale performance and acceptability among the diverse populations served in real-world primary
and oncology care settings. Our specific aims are to: Aim 1. Develop psychometrically sound clinician-specific
and overall team SDM-S subscales for each decision phase; Aim 2. Evaluate and compare the predictive
validity of the clinician-specific vs. overall team SDM-S subscales across and within decision phases; and Aim
3. Evaluate patient acceptability of SDM-S scales in real-world primary and oncology care settings. Results will
enable monitoring the phase-specific quality of SDM-S provided within today’s team-based care models across
diverse cancer screening/treatment decisions and patient subgroups. As such, study findings will provide
actionable targets for those wanting to monitor and improve patient-centered care and important measurement
tools for those studying the impact of SDM on patient and other outcomes.
1

Public health relevance
Project Narrative We are developing a new and rigorously tested measure of shared decision making that can be used by health care leaders and others wanting to monitor and improve the quality of decision-making support provided to patients facing cancer screening and treatment decisions. Our measure is different from existing measures of shared decision making in that it considers the decision-making support patients receive from different care team members across each of four decision-making phases: choice awareness, consideration of alternatives/preferences, choice-making, and choice implementation. It is important to be able to measure and understand decision-making quality within and across these decision-making phases as health care providers and others explore new and innovative ways to implement shared decision making in practice.